Development of a Once-Weekly AND Glucose-Responsive Insulin Formulation

PROJECT SUMMARY:
An ever-expanding arsenal of insulin variants with customizable pharmacokinetics has enhanced the standard
of care for individuals with diabetes. Rapid-acting options are employed alongside mealtime, while long-lasting
analogs offer basal support throughout the day. However, developing insulin variants that dynamically adjust
bioavailability and potency in response to changes in glucose levels, aligning with real-time therapeutic need,
remains an ongoing target. The realization of this long-sought vision of glucose-responsive insulin has the
potential to simplify dosing protocols and improve glycemic control, effectively mitigating both hyperglycemic
and hypoglycemic episodes and their associated health complications; insulin therapy would instead be ready
to respond to elevated blood glucose levels as needed. Meanwhile, the clinical impact of once-weekly
antidiabetic medications (e.g., GLP-1 analogs) underscores the benefits of reduced dosing frequency in
enhancing therapeutic adherence. While once-weekly insulin is a near-term clinical possibility, the development
of glucose-responsive insulin has proven more elusive. In this project, we present a platform aimed at
achieving both week-long AND glucose-responsive insulin from a single injection. Our preliminary approach
involved chemically modifying insulin with a novel glucose binder in combination with a dendrimer carrier. This
approach coupled electrostatic complexation with glucose-sensing dynamic-covalent bonding to create a
subcutaneous nanocomplex insulin depot. Early results support the ability of this depot to respond to glucose
challenge by promptly increasing serum insulin levels, as well as its ability to sustain function for at least a
week in a diabetic swine model. However, the translation of this technology to clinical use may encounter
certain challenges. This proposal focuses on addressing these anticipated hurdles and further validating the
platform. One key concern is that chemical modification of insulin can reduce its potency and receptor binding
affinity. To mitigate this issue, we will explore alternative linkers and conjugation strategies to minimize the
impact of chemical modifications on insulin function. Additionally, the dendrimer carrier presents potential risks
related to toxicity, limited biodegradation, and clearance. Drawing inspiration from degradable cationic carriers
commonly used in gene delivery, we will investigate versions that offer improved biocompatibility and
clearance. We will validate optimized formulations for their efficacy in diabetic rodents and assess their
glucose-specific potency in rodent glucose-clamped models. Finally, we will confirm therapeutic function of our
improved platform in a "human-sized" diabetic swine model, both in response to simulated meals and in the
context of long-term blood glucose control with once-weekly dosing. Our innovative strategy to develop a
week-long AND glucose-responsive insulin depot holds promise as a clinically viable product with direct impact
on the lives of a rapidly growing population of individuals with all forms of diabetes.

Public health relevance
PROJECT NARRATIVE: To better manage both the acute and chronic complications associated with blood glucose instability, there remains a critical need for new therapeutics that can adjust the availability and potency of insulin according to need, and also offer a simplified dosing schedule. We have developed an initial approach to use the combination of electrostatic and dynamic-covalent interactions between a dendrimer carrier and a synthetically modified insulin to afford a once-weekly AND glucose-responsive insulin depot. This project will focus on further optimizing this approach, addressing its remaining challenges and shortcomings with an eye toward clinical translation.